Washington University Institute of Clinical and Translational Sciences

PROJECT SUMMARY
This application is submitted in response to NOT-TR-20-014 as a supplement to Parent Award UL1TR002345,
the Washington University Institute of Clinical and Translational Sciences (WU ICTS). The NCATS prior
approval process for Clinical and Translational Science Awards (CTSA) human subject research (HSR)
requires study information to be entered into the NIH eRA Human Subjects System (HSS). This requirement
applies to Pilot projects supported directly with CTSA grant funding or voluntary committed cost sharing and
KL2 Scholar projects that involve HSR. The entry of these studies into the HSS along with NCATS-specified
documentation and email notification are required before the project can begin.
The overall goal of this CTSA Administrative Supplement is to add a dedicated Quality Assurance/Quality
Control position to the WU ICTS Administrative Core. Their role is to coordinate and collaborate with KL2
Scholars and Pilot PIs regarding CTSA-related submissions to NCATS, submissions to the HSS, and
management of this overall prior approval process. The specific aims are included below.
Aim 1: QA/QC personnel will oversee and manage internal processes for human subjects research (HSR)
prior approval requests to facilitate consistency and efficiency and enhance the submission of successful
CTSA-related information packages to NCATS.
Aim 2: QA/QC personnel will implement a comprehensive evaluation strategy to guide decision-making and
ensure continuous improvement in processes.

Public health relevance
Project Narrative The regulatory processes involved in translating biomedical discoveries into clinical applications are complex and rapidly evolve over time, which can often create barriers to timely translation. A goal of the Clinical and Translational Sciences Award program is to tackle system-wide scientific and operational changes that solve many outstanding problems limiting the efficiency, effectiveness, and reach of clinical and translational research. This supplement application intends to support this goal by improving the consistency, efficiency and enhancement of regulatory processes.